UNC Integrated Translational Oncology Program (UNC-iTOP)

Abstract
The University of North Carolina at Chapel Hill Integrated Translational Oncology Program (UNC-iTOP) is a
T32 training program focused on training clinicians (MDs), basic scientists (PhDs), and PhD, MD and MD-PhD
candidates in clinical/translational disease based research at the interface of clinical oncology and cancer
biology using patient samples. We have recruited preceptors/faculty with broad interests who are committed to
improving translational oncology and tissue-based research. Led by two physician-scientists with
complementary expertise in tissue-based research, clinically applicable preclinical models, and clinical trials,
UNC-iTOP has recruited preceptors/faculty who are leaders in their fields. The UNC-iTOP faculty includes
members with expertise in translational research focusing on biomarkers of cancer and novel therapies and
interventions for patients. All UNC-iTOP faculty have approved IRB protocols and have led prospective clinical
protocols and/or trials.
Support for UNC-iTOP will enable a proactive, energetic and sustained effort to identify, recruit and train
promising MD, PhD, and MD-PhD investigators for research careers that will address the knowledge gap in
tissue-based translational oncology research. Translational oncology tissue-based research has been critically
important for the identification of key drivers of cancer initiation, progression and metastasis. Identifying
treatments that target the vulnerabilities at each stage continues to be a broad area of need. Evaluating new
therapies in relevant models with more stringent metrics is key to translating findings to the clinic. Validating
findings in patients is the overarching goal. To succeed in each area requires a fundamental understanding of
the workings of the healthcare and clinical protocol/regulatory system that supports cutting edge research.
UNC-iTOP will provide a comprehensive training program for MD and PhD trainees committed to translational
oncology and tissue-based research. We recognize that translational oncology research involves numerous
disciplines and successful advances are the result of interdisciplinary teams. The UNC-iTOP focuses on
integrating the “basic”, “clinical”, and “regulatory” teams early on with the overarching goal to develop a cadre
of translational scientists (both MDs and PhDs) who will be the next generation of leaders in the field of
oncology research.

Public health relevance
Narrative The UNC Integrated Translational Oncology Program (UNC-iTOP) is a T32 training application from the University of North Carolina at Chapel Hill (UNC) focused on training clinicians (MDs), basic scientists (PhDs), and MD-PhD candidates in clinical/translational disease based research at the interface of clinical oncology and cancer biology using patient samples. The UNC-iTOP is unique in its focus on developing clinician/scholars in translational oncology tissue-based research, integrating 1) physicians (residents and fellows) training in Medical, Surgical, and Gynecologic Oncology with post-doctoral fellows possessing PhD degrees and 2) MD, MD-PhD, PhD pre-doctoral candidates. UNC-iTOP will provide research training support for up to two years and will support three post-doctoral and one pre-doctoral trainees per year with a post-doctoral trainee ratio of 2 MD/MD-PhD: 1 PhD.